Sickle cell disease and the functional circuit of adult-born neurons in the dentate gyrus

Project Abstract
Cognitive deficit is a debilitating complication of SCD. It affects all stages of life in terms of overall quality of life,
from academic performance in children, to educational attainment in young adults, and employability and job
retention in adults. Accumulating evidence in both human and mouse studies points to a multifactorial
pathobiology of cognitive deficits in SCD. Notably, cognitive impairments worsen with increasing age, suggesting
that age-related neurobiological changes in the brain may contribute to the development of cognitive deficits in
SCD. One such change affected by aging is adult neurogenesis. Studies in non-SCD populations have identified
aging as a negative regulator of adult neurogenesis that occurs concurrently with cognitive decline and increased
inflammation. Although SCD has features of accelerated aging, in conjunction with elevated systemic
inflammation and cellular evidence of neuroinflammation, how these common complications of the disease may
affect adult neurogenesis in the hippocampus or its involvement in cognitive impairment is not clear. Our group
recently showed that age and neuroinflammation affect cognitive function in sickle cell mice in "aged" (13 months
old) mice compared to aged-matched control mice, with neurogenesis skewed more towards gliogenesis in aged
sickle cell mice compared to age-matched controls. However, the effect of this on the functional integration of
adult-born neurons into the neurocircuitry in sickle cell mice is unknown. This diversity supplement seeks to fill
this knowledge gap in pathobiology involved in the development of cognitive deficits in SCD. We hypothesized
that aging and inflammation in SCD alter the functional circuitry of adult-born neurons in the dentate gyrus and
may partly underlie the development of cognitive deficit. We postulate that aging and inflammation affect the
integration of adult-born neurons into the pre-existing neurocircuitry and contribute to the development of
cognitive impairment in sickle cell mice. We will explore the impact of aging and inflammation on adult
neurogenesis in SCD by using a monosynaptic GFP-tagged retrovirus labeling approach. We aim to: (1)
investigate the extent of functional integration of adult-born neurons in sickle cell and AA control mice at the
onset of cognitive decline and correlate this with performance on hippocampus-based memory and learning
tests; (2) we will also treat another group of mice with minocycline (anti-neuroinflammation), determine functional
integration of adult-born neurons, and document cellular evidence of neuroinflammation with
immunohistochemistry. These will be related to cognitive deficits in treated and non-treated mice. The
significance of the knowledge gained from this project would advance our understanding and enable us to identify
potential novel targets for preventing or attenuating cognitive impairment in SCD.

Public health relevance
Project Narrative Cognitive impairments are a sequela of SCD and a significant health burden with complex risk factors. Our study identified aging and neuroinflammation as mechanisms contributing to cognitive deficits in the SCD mouse model, with adult neurogenesis appearing to be skewed towards gliogenesis in SCD, but it is unknown how these adult-born neurons in SCD are affected by aging and inflammation. This project will evaluate the impact of aging and inflammation on the integration of adult-born neurons into the existing neurocircuitry or lack thereof and the development of cognitive deficits in the SCD mouse model.